Consortium Coordinating Center for Social, Behavioral, and Economic Research on COVID-19

Project Summary/Abstract
Over the past 60 years, the Inter-university Consortium for Political and Social Research
(ICPSR) has successfully coordinated the research needs for over 800 universities and
research institutes. This work has led to the expanded use of secondary data, the development
of innovative lines of research, and the training of multiple generations of scholars across the
fields of social and behavioral sciences. The role of the social sciences in understanding major
health challenges and disasters has expanded rapidly over the past several decades, and
ICPSR in partnership with the Institute for Social Research (ISR) has played a key role in
offering an infrastructure to support this work. New areas and new directions have emerged
(e.g., population health, social determinants of health, health equity, growth of longitudinal
studies, and complex national population-based surveys). ICPSR has been able to bring
together and share cutting-edge research emerging from cross disciplinary collaborations in a
systematic manner using an open science model of information distribution. An ICPSR-led
consortium model for social, behavioral, and economic (SBE) research will provide a nexus for
communication, streamlining information-sharing across the behavioral and social science
community, multiple NIH Centers, and to the public. This proposal creates a new independent
Social, Behavioral, and Economic Research on COVID-19 Consortium Coordinating Center
(SBECCC) for COVID-19 related research. The new SBECCC will include resources and
support for research specific to COVID-19. To maximize the growth of cross-disciplinary
research, its mission will also expand to promote collaborative work between the funded U01
projects, other NIH Research Centers, and a multidisciplinary research community each with
different missions, cultures, and ethos. The SBECCC will involve experts from the Survey
Research Center in ISR, the Program for Research on Black Americans in ISR, and the Center
for Health and Research Transformation at the University of Michigan to develop the
consortium, SBE research projects, and produce dissemination materials that aggregate and
synthesize research findings emerging from NIH investments in COVID-19 research.

Public health relevance
Project Narrative This proposal aims to launch a Consortium Coordinating Center to serve the goals of facilitating communication between Social, Behavioral, and Economic Research on COVID-19, facilitating collaboration within and across the funded U01 projects, associated NIH Centers, and disseminating research advances, activities, and resources to a broad audience of stakeholders. Through these efforts, the Consortium Coordinating Center significantly magnifies the impact of SBE activities and findings.